2021 NHIS Cancer Control Supplement: Cancer Questions on the 2021 National Health Interview Survey

The purpose of this agreement is for the National Cancer Institute (NCI) to provide financial support to the National Center for Health Statistics (NCHS). The NCI funds provide partial support for the National Health Interview Survey (NHIS) to collect cancer control data. This project is a collaborative effort between NCHS, NCI and the National Center for Chronic Disease Prevention and Health Promotion (NCCDPHP). A separate intra-agency agreement exists between NCCDPHP and NCHS. Pertaining to the National Health Interview Survey in general and cancer questions specifically, this agreement pays a portion of all costs associated with the implementation of the NHIS including questions on cancer. These functions include but are not limited to: • Sample design and maintenance • Sample selection and listing • Questionnaire design and testing • Expert consultation • Programming and testing of the CAPI instrument • Interviewer training and data collection • Post data collection editing and processing • Oversight and management of the operations • Data weighting and estimation • Preparation and submission of all OMB and IRB clearances packages • Preparation of Public Use Data Files • Data publications, presentations and analysis • Travel related to any of the above mentioned items Many of these functions are provided in whole or in part by the Census Bureau. In addition to the above mentioned tasks NCHS collaborated with NCI and NCCDPHP to develop the cancer questions. NCHS retains the right to final approval of the content of the sponsored questions, with the objective of maintaining quality, appropriateness, and cohesiveness of the entire survey. NCHS will collaborate with NCI in the editing of the data if it is determined that it is necessary for data quality assurances. Should sharing of data be required for the purpose of editing, NCI agrees to comply with all NCHS and other federal requirements to ensure data integrity, security and confidentiality. NCHS may share data for the purposes of editing through pre-tabulated tables provided by NCHS, through the use of the Research Data Center (RDC), or by the transfer of selected data. Transfer of data would require NCI to complete the requirements and sign a separate Designated Agent Agreement and depending on the type of data transferred, demonstration of an accepted System Security Plan including an Authority to Operate granted or acknowledged by the CDC Office of the Chief Information Security Officer. Supplement sponsors shall not use the opportunity to edit data for the purpose of working on or disseminating results of their own separate analyses before the supplement microdata are publicly released. NCHS anticipates the release of the public use data file approximately 6-9 months after the end of the data collection year and will post the public use data file on our website http://www.cdc.gov/nchs/nhis.htm.